Mechanisms of Mucosal and Systemic Immunity to Vaccination and Infection with Enteric Pathogens in Children and Adults

Overall - Abstract
Enteric bacterial infections are a significant global health concern, particularly in developing nations, where
they disproportionately affect children. These diseases include typhoid fever (caused by Salmonella enterica
serovar Typhi -S. Typhi-), invasive non-typhoidal Salmonella (iNTS; e.g., S. Enteritidis, S. Typhimurium), and
shigellosis (caused by multiple Shigella serotypes). Limited knowledge of systemic and local gut immunity,
including immunological correlates of protection, for human-restricted enteric pathogens (e.g., Salmonella and
Shigella) continues to hamper vaccine development. Importantly, very limited information is available regarding
immune responses to these enteric pathogens in children. To address these major shortcomings, it is
imperative that studies involving human-restricted infectious agents are performed in children and adults. Thus,
we are proposing under the central theme of “Mechanisms of Mucosal and Systemic Immunity to Vaccination
and Infection with Enteric Pathogens in Children and Adults” to further our understanding of the protective
immunological mechanisms that can be elicited systemically and in the gut microenvironment by using
exclusively human based models with major human-restricted pathogens, i.e., Salmonella (S. Typhi, S.
Typhimurium S. Enteritidis) and Shigella flexneri 2a. These studies will use unique specimens from clinical
studies (Core 1) in which participants are immunized, or not, with parenteral or oral candidate vaccines against
these major enteric bacterial pathogens, and, in some cases, followed by challenge with wild type organisms
(Research projects -RP- 1-2). This will allow us to examine the mechanisms (e.g., epigenetic modifications)
involved in the induction and maintenance of human adaptive immunity associated with protection.
Furthermore, because of the critical importance of innate immunity elicited in the gut, we will use explant
tissues and advanced in vitro models of the human gut mucosa (e.g., enteroids) to study the early crosstalk
between epithelial cells and innate immunity and the epigenetic mechanisms at play in the gut
microenvironment following exposure to Salmonella and Shigella (RP3). The mechanisms underlying immune
responses will be studied using advanced technologies e.g., suspension mass cytometry, imaging mass
cytometry (Core 3), EpiTOF, ATAC-seq, transcriptomics (RNA-seq), phosphoflow, and single-cell RNA-seq
(RP1-3). Mechanistic studies using unique human specimens, gut organoids and explants will employ common
methods of analysis and tools and the same wild type and attenuated bacterial strains. A world-class team of
systems biologists (Core 2) will integrate immunological and omics data. The proposed strategy involves
synergistic interactions among all RP’s and Cores supported by an interdisciplinary team of renowned
scientists in immunology, clinical studies, genomics, epigenetics, bioinformatics, modeling, biostatistics and
adjuvants. The long-term goal of this “Enteric CCHI” is to advance our knowledge of systemic and gut human
immunity to accelerate the development of novel and better vaccines for enteric bacterial pathogens.

Public health relevance
PROGRAM OVERALL – Project Narrative - CCHI Enteric bacterial infections include different types of diarrheal illnesses caused by pathogenic Salmonella and Shigella which afflict major populations around the world, particularly in developing nations, disproportionally affecting children. The development of new and improved vaccines is hampered because we do not fully understand how the human immune system operates to protect children and adults from these infections. To address these problems, the central theme of our “Mechanisms of Mucosal and Systemic Immunity to Vaccination and Infection with Enteric Pathogens in Children and Adults” CCHI application is to further our understanding of the immune mechanisms that operate in both systemically and in the gut mucosal environment, by using unique human infection and vaccination models of Salmonella and Shigella.